Empowering Latinas to Obtain Guideline-Concordant Breast Cancer Screenings

ABSTRACT
Latinas suffer disproportionately from late stage breast cancer (BC) diagnoses and worse post-diagnosis
quality of life relative to non-Latina Whites (NLWs), in part due to lower guideline-concordant screening.
Education+navigation (educate) approaches have offered Latinas community education to address
psychosocial barriers (e.g., fear) and navigated Latinas to free/low-cost breast cancer care. Our
transdisciplinary team has developed a promising empowerment+navigation (empower) approach that may
lead to greater BC screening among Latino networks. In the empower approach, Latinas who are non-adherent
to US Preventive Services Task Force (USPSTF) guidelines learn about BC; are navigated to free/low cost
breast cancer care; and gain communication skills to promote BC screening throughout their networks.
Our premise is that empowering non-adherent Latinas as breast health agents may lead to greater BC
screening among non-adherent Latinas and their networks than treating non-adherent Latinas as passive
recipients of education. The current proposal tests our premise and identifies “active ingredients” of the
empower approach.
In Aim 1, we will conduct an individual randomized controlled trial (RCT) in a federally qualified health center
(FQHC). This trial will build on our team’s current service projects to provide free/low-cost BC screening in the
FQHC, including leveraging its relationship with a community organization committed to leadership
development among Latinas. Among non-adherent Latinas, we will compare the effects of empower and
educate approaches on initial and repeat BC screening, in line with USPSTF guidelines.
In Aim 2, we conduct an observational social network study. We will recruit network members through non-
adherent Latinas enrolled in our RCT. Among network members, we will compare the effects of empower and
educate approaches on initial and repeat BC screening across four years.
In Aim 3, we will explore theoretical mechanisms of change that could contribute to intervention differences in
BC screening. For non-adherent Latinas’ BC screening, we will examine the mediating roles of greater BC
knowledge and motivation to be healthy role model. For network members’ BC screening, we will examine the
mediating role of non-adherent Latinas’ enhanced capacity to promote BC screening. Specifically, we will test
the independent effects of volunteerism in community BC initiatives, potential to “bridge” network members
with formal change agents (e.g., community health workers, navigators), acceptability to promote BC, feasibility
to promote BC, and BC promotion to network members.
Our innovative, robust approach has direct implications for expediting the translation of promising community
interventions into practice.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to improve the guideline-concordant breast cancer (BC) screening among Latinas living in Chicago, by testing a new empowerment (empower) approach - wherein non-adherent Latinas are empowered to become informal breast health leaders in their community and are navigated to affordable, accessible care. We will examine if, relative to traditional approaches, the empower approach leads to greater BC screening among non-adherent Latinas and women in their social networks. We will also explore and identify the “active ingredients” that lead to greater BC screening in the empower approach - including greater knowledge, motivation to be a healthy role model, volunteerism in community BC initiatives, potential to “bridge” network members with formal change agents (e.g., community health workers, navigators), acceptability to promote BC, feasibility to promote BC, and BC promotion to network members.